Inclusion of Diverse and Medically Underserved Populations in the Design and Implementation of the PREMMplus Patient-Facing App

Project Summary/Abstract
The increasing use of genetic testing and the development of syndrome-specific risk models has transformed
hereditary cancer risk assessment. We were funded under R01CA132829 awards (4/1/2008–present) to de-
velop the PREMM1,2,6, and PREMM5, risk assessment models, which use family history to identify individuals
with a clinically significant risk of carrying a germline pathogenic variant (PV) associated with Lynch syndrome
(LS). These models are recommended by national guidelines and widely used. We subsequently developed
the PREMMplus model to keep pace with the changing practice of multigene panel testing for several heredi-
tary cancer syndromes. PREMMplus predicts risk of carrying a PV in one of 19 genes implicated in 18 heredi-
tary cancers and was developed and validated from patient data of approximately 30,000 patients. Published in
Journal of Clinical Oncology this year, the model demonstrated greater than 90% sensitivity and negative pre-
dictive values. Despite progress in the development of better methodologies for risk assessment and the fact
that national guidelines recommend familial cancer risk assessment in primary care, these assessments are
rarely performed, leaving many patients with hereditary cancer syndromes unidentified. Patients from marginal-
ized backgrounds are even less likely to receive guideline-directed risk assessment and genetic testing, result-
ing in cancer health inequities. Providers report multiple barriers to conducting risk assessment, including time
in the clinical appointment, knowledge of risk criteria, and limited numbers of genetic counselors. Risk assess-
ment that can provide comprehensive and systemic identification of inherited cancer risk, along with clear clini-
cal decision support for providers is a critical unmet need. Further, this risk assessment must be integrable into
clinical workflows as well as scalable and sustainable in diverse clinical settings. To increase access to com-
prehensive cancer risk assessment, we have developed a patient-facing PREMMplus electronic health applica-
tion (app). We propose to use an implementation science approach to design and evaluate scalable and
sustainable implementation strategies; we will conduct our implementation science study in 5500 patients
from 3 diverse community health settings, each of which serves a unique medically marginalized popula-
tion. We will refine the app and implementation strategies – tailoring them to the unique needs of each site – in
a year-long pre-implementation phase. We will use mixed-methods approaches to evaluate the outcomes of
this study against multiple strong theoretical frameworks. To accomplish these goals, we propose the following
Specific Aims: 1) Evaluate a patient-facing PREMMplus app in diverse community health settings in a large
multi-center implementation study, 2) Evaluate barriers and facilitators to systematic hereditary cancer risk as-
sessment and refine long-term strategies for scalability and sustainability, and 3) Build EHR-compatible appli-
cations and evaluate their ability to further increase sustainability and scalability. This project will produce an
approach to hereditary cancer multigene testing that is scalable and sustainable in many healthcare systems.

Public health relevance
Project Narrative We will design implementation strategies for systematic, comprehensive, and validated hereditary cancer risk assessment. Our goal will be to design strategies that are sustainable, scalable, and equitable in diverse settings and many patient populations. We will test these strategies in 3 diverse community health systems.